Role of p70S6 kinase in the synaptic and behavioral deficits induced by stress

DESCRIPTION (provided by applicant): Depression is a debilitating neuropsychiatric disorder that affects ~17% of the US population at some point in their lives (Kessler et al., 2003). Currently approved medications can require several weeks to achieve efficacy and many patients never achieve complete remission of depressive symptoms. It is therefore critical to better understand the underlying causes of depression and identify novel treatment strategies that can improve patient outcome. It is thought that depression may be caused, at least in part, by exposure to chronic stress. Chronic stress has detrimental effects on the morphology and function of neurons in the prefrontal cortex and hippocampus. Recent evidence has identified that the drug ketamine produces rapid and robust effects in depressed patients (Berman et al., 2000; Zarate et al., 2006) and studies in rodents have found that these robust effects are due to activation of a cell signaling pathway involving mTOR and p70 S6 kinase, which is required for the antidepressant response (Li et al., 2010). Activation of these signaling pathways leads to increased excitatory synapses in the prefrontal cortex and reverses the negative effects of stress on these synapses (Li et al., 2011). The project proposed here aims to determine if increasing the activity p70 S6 kinase alone is sufficient to produce antidepressant effects and increase resilience to the behavioral and neuronal insults produced by exposure to chronic stress. This will be achieved by using a viral vector to deliver a mutant, constitutively active version of p70 S6 kinase to the prefrontal cortex or hippocampus of rats before exposure to chronic stress. Following viral expression, rats will be exposed to chronic stress and assessed for behavioral deficits and neuronal atrophy produced by stress. It is anticipated that increasing the activity of the p70 S6 kinase pathway will prevent depressive-like behavior in rats and protect neurons from the deleterious effects of stress. The data obtained here will provide important insight into molecular events that underlie stress resilience and can help identify and elucidate novel pathways and treatment strategies for depression.

Public health relevance
PUBLIC HEALTH RELEVANCE: Major Depressive Disorder (MDD) is a prevalent mental illness that impacts the lives of roughly 17% of the US population at some point in their lives and can have devastating personal and societal costs. Currently available treatments for depression are effective in only a subset of patients and can require weeks of treatment to achieve minimal efficacy. The proposed project will provide important insight into the molecular mechanisms that mediate resilience to stress and antidepressant response and will guide development of novel therapeutics for depression with more robust and rapid- acting effects. __SpecificAimsTextDelimiter__ Specific Aims: Our lab has recently identified a key role for mTOR and p70 S6 kinase in mediating the effects of chronic stress and the rapid antidepressant response produced by ketamine (Li et al., 2010; Li et al., 2011). Recent clinical studies have also identified deficits in the mTOR/p70 S6 kinase pathway in patients with Major Depressive Disorder (Jernigan et al., 2011). The focus of this proposal and the aims listed below is to determine if increased signaling through p70 S6 kinase is sufficient to produce behavioral and neuronal resilience to stress. Aim 1: Development and validation of an AAV2 viral vector that expresses a constitutively active mutant of p70 S6 kinase 1. Studies have been underway to develop a an AAV2 vector expressing a constitutively active mutant of p70 S6 kinase 1. Preliminary data suggests that this virus expressed the appropriate proteins and functions as a constitutively active p70 S6 kinase 1 mutant leading to downstream phosphorylation of substrate proteins. Studies will be performed to characterize the expression of this protein and subcellular localization in neurons. Aim 2: Determine if increased p70 S6 Kinase 1 activity in vivo is sufficient to produce stress resilience in behavioral models. I will infuse control or p70 S6 kinase 1 mutant virus into the mPFC and the CA3 pyramidal cell layer of the hippocampus and expose rats to chronic unpredictable stress (CUS) to determine if increased p70 S6 kinase signaling is sufficient to produce resilience to the behavioral deficits produced by chronic stress in sucrose preference, forced swim test, novelty-suppressed feeding and the elevated plus maze. Aim 3: Determine if increased p70 S6 Kinase 1 activity in vivo is sufficient to prevent stress-induced alterations in neuronal morphology. There is a large body of evidence that chronic stress produces neuronal and synaptic atrophy in the mPFC and CA3 hippocampus. I will express control or p70 S6 kinase 1 mutant in these regions and expose rats to chronic stress to determine if increased p70 S6 kinase 1 signaling is sufficient to prevent stress-induced neuronal debranching, synaptic loss and decreased synaptic protein content.